Protocol Review and Monitoring System

The Simmons Comprehensive Cancer Center (SCCC) Protocol Review and Monitoring System (PRMS) provides
independent peer review for scientific merit, prioritization, and monitoring for all cancer-related clinical and
population science studies conducted at the UT Southwestern Medical Center (UTSW) and its affiliated
healthcare systems, Parkland Health and Hospital System and Children’s Medical Center. PRMS functions are
accomplished by a rigorous review in a two-stage process conducted by: 1) SCCC Disease-Oriented Teams
(DOTs), where initial assessment of value, fit, and prioritization within the existing portfolio of studies is
performed, as well as an assessment of each study’s operational and accrual feasibility; and 2) the Protocol
Review and Monitoring Committee (PRMC), which is the definitive independent authority for determining which
studies proceed to activation. The PRMC ensures that all SCCC-aligned cancer research studies involving
human subjects are (1) scientifically sound, (2) effectively designed, (3) appropriately prioritized within DOT
research portfolios, (4) aligned with SCCC institutional clinical research priorities, (5) feasible for completion, (6)
inclusive of appropriate data and safety monitoring plans, and (7) monitored regularly for accrual and scientific
progress. Utilizing standard operating policies and procedures, the PRMS is conducted by 13 DOTs and three
PRMCs (two for clinical studies and one for population studies), under the leadership of Hans Hammers, MD,
PhD (PRMC1), Robert Timmerman, MD (PRMC2), and Simon Craddock Lee, PhD, MPH (Population Science
PRMC). During the current project period, the PRMS made substantial progress in key areas, including
implementing parallel review with the Institutional Review Board (IRB) while still requiring PRMC approval before
IRB approval, increasing PRMC meeting frequency, expanding PRMC membership, and transitioning to a fully
electronic review process, all of which have contributed to decreased review timelines while maintaining the
highest scientific standards. In 2019, the SCCC DOTs vetted 197 studies for potential submission and forwarded
162 studies for PRMC review. Of these, 50 had undergone an appropriate external scientific peer review and
therefore received an expedited review by the PRMC Chair and/or Vice Chair. The remaining 112 studies,
primarily representing SCCC investigator-initiated and industry-sponsored trials, were forwarded for full PRMC
review. More than 70% of the studies reviewed by PRMC required modifications prior to being approved. No
studies were disapproved. Ten underperforming studies were closed. In the next CCSG cycle, the PRMS will
focus on further reduction in review timelines and enhancing information provided to investigators during the
review process.